Modulating the pharmacodynamics of methamphetamine and fentanyl co-use via hypocretin pathways

PROJECT SUMMARY/ABSTRACT
Stimulant and opioid dependence are major public health problems and the number of people illicitly using
drugs of abuse in combination is rising. In fact, opioid and opioid co-involved overdose related fatalities
regrettably reached a devastating new high of more than 107,000 deaths in 2021. Co-use of stimulant and
opioids, or polysubstance use, is increasingly reported in clinical survey data, highlighting the need to study the
pharmacodynamics of polysubstance use. Uncovering the mechanisms and neurocircuitry underlying
polysubstance use is essential to understanding and treating co-existing stimulant and opioid use disorders. Yet,
current research primarily targets stimulant or opioid dependence in isolation, thereby limiting discovery of
interventions for polysubstance use disorders. The hypocretin/orexin neuropeptide system has been widely
implicated in mechanisms of drug addiction, across all classes of drugs and alcohol. Given the universal effect
of hypocretin-receptor blockade on mitigating highly motivated drug-taking in animal models, the hypocretin
system is a logical target for treatment of polysubstance use disorders in humans. Nonetheless, the role of
hypocretin signaling in combined methamphetamine and fentanyl use remains to be examined. The overarching
hypothesis of this proposal is that additive opioids, such as fentanyl, enhance methamphetamine self-
administration, and that hypocretin signaling within stress-sensitive brain regions of the extended amygdala and
the lateral habenula is a key modulator of the enhanced motivation associated with polysubstance use and
dependence. Thus, this proposal aims to elucidate the pharmacodynamic nature of polysubstance use across
the development and trajectory of dependence utilizing a rat model of concomitant methamphetamine and
fentanyl intravenous self-administration (Aim 1) and to systematically examine the hypocretin-related
neurobiological mechanisms and neurocircuitry underlying polysubstance dependence using
neuropharmacological and chemogenetic DREADDs techniques (Aims 2 & 3). The data obtained from these
studies will broaden our understanding of the underlying mechanisms of drug dependence and identify novel
therapeutic interventions for treatment of polysubstance use disorders.

Public health relevance
PROJECT NARRATIVE Stimulant and opioid dependence are major public health problems and the number of people illicitly using drugs of abuse in combination is rising, perpetuating addiction and the current devastating overdose crisis. The hypocretin neuropeptide system has been widely implicated in mechanisms of drug addiction, yet the role of hypocretin signaling in combined stimulant and opioid use remains to be examined. The current proposal consists of preclinical studies that aim to elucidate the pharmacodynamics of methamphetamine with fentanyl co-use and define the hypocretin-related neurocircuitry underlying polysubstance self-administration and stress- induced reinstatement of drug-seeking, ultimately to ascertain a novel therapeutic target for polysubstance use disorders.